Technology Core

Through the activities in this Technology Core, we will provide comprehensive high-throughput genome
sequencing and analysis to the investigators participating in this U19 proposal to advance research in all four
projects that are focused on understanding host, pathogen, and microbiome interactions as determinants of
infectious disease outcome. We will provide standard high throughput genome, transcriptome, metagenome,
metatranscriptome, and single cell sequencing as well as other standard sequencing methods required by our
Viral, Bacterial, Fungal, and Parasite research projects and any future collaborative pilot projects. This
includes sequencing on every major sequencing platform including Illumina, Pacific Biosciences, and Oxford
Nanopore. We will also provide custom sequencing approaches for the study of infectious disease, when
necessary, building on our immense experience on sequence and analysis of polymicrobial samples. We will
use the latest sequencing and analysis tools to improve genome annotation, providing an important resource to
the infectious disease community. We will focus our research and development activities on developing a
robust single cell transcriptomics for the analysis of host-pathogen samples, including single cell
transcriptomics on prokaryotic pathogens lacking polyadenylated transcripts. We will encourage and support
the implementation and analysis of genome editing approaches that are described within the projects. Lastly,
we will integrate our Technology and Data Cores to seamlessly transition sequencing data and novel
analysis tools generated in the Technology Core to the Data Core.